Project 2: InHANCE: Radiation Associated Dysphagia

ABSTRACT: Project 2
Radiation-associated dysphagia (RAD) is a leading driver of QOL and a potentially life-threatening adverse
treatment sequelae, afflicting more than half of patients treated with curative radiotherapy (RT) for head and
neck cancers (HNC). Aspirators are almost 5-times more likely to develop pneumonia than non-aspirators, and
pneumonia confers a 42% increased risk of mortality among HNC survivors. RAD is a radiation dose and field
dependent phenomena. Despite laudable progress to define dysphagia-aspiration related structures (DARS),
their normal tissue complication probabilities (NTCP), and level 1 evidence for their dose constraints (i.e.,
ISRCTN25458988), critical opportunities remain to advance care by innovating the evidence base for RT
field/dose reduction via personalized care pathways and clinical trials. Using the investigators’ one-of-a-kind
PRO-ACTIVE trial (NCT03455608) dataset, we propose to first accomplish this using InHANCE P01 core
resources to define effect modification of the dysphagia-RT dose-response relationship by pragmatic co-factors
like age and multi-modality treatment – factors known to influence in uncertain magnitude the radio-sensitivity
and functional reserve or the ability of an individual survivor to compensate for neuromuscular RT injury. The
investigators will next exploit the integrated InHANCE P01 infrastructure to for the first time characterize the soft
tissue toxicity profiles underlying RAD risk-reduction using image-based RT field reduction by Tc99-
lymphoscintigraphy (SPECT-CT) in oropharyngeal cancer. Finally, the investigators will use deep learning to
deliver an interpretable AI tool to help investigators more efficiently and reliably clinically implement the image
based swallowing grading method we developed called DIGEST (PMC5161634). The long-term goal of this work
is to reduce dysphagia burden through clinical adoption of pragmatic imaging innovations. Our central
hypothesis is that pragmatic imaging algorithms and image-guided RT field reduction can improve dysphagia
care through improved risk stratification, classification, primary prevention of RAD. The objective of the proposed
studies is to analyze and augment imaging sets from 4 large existing data sources to: 1) develop risk-stratified
normal tissue complication probability (NTCP) models of RAD (Aim 1), 2) deliver image-based swallowing
secondary endpoint and lymphedema/fibrosis characterization after SPECT-CT image-guided RT field reduction
(Aim 2), and 3) deliver a clinically interpretable automated DIGEST grade for clinical use (Aim 3). Using
integrated Core support from the InHANCE P01 Program to process and analyze RT planning CT, MRI, and
radiographic MBS imaging studies linked to clinical data, we are uniquely positioned to address these
complementary aims. We expect this work to deliver practical quantitative imaging solutions to help real-world
clinicians detect: 1) who will get RAD (Aim 1), 2) LEF and RAD mitigation through image-based RT field reduction
(Aim 2), and 3) classification of RAD (Aim 3).

Public health relevance
NARRATIVE: Project 2 The incidence of highly curable head and neck cancers is rapidly rising, and radiation treatment is very commonly given at doses sufficient to cause chronic dysphagia (difficulty swallowing). Swallowing function is a driver of quality-of-life (QOL) after cancer treatment and may cause death from treatment side effects (pneumonia) even after cancer is cured. This application seeks to understand how quantitative imaging methods might reduce dysphagia burden through risk stratification, automated diagnostics, and image-guided de-escalation algorithms.